University of Rochester Medical Scientist Training Program

The University of Rochester has a long history of training physician-scientists, with numerous alumni contributing
to biomedical research and assuming leadership positions at academic medical centers. There is a continued
and growing need for physician-scientists, who serve a unique role in translating research discoveries to the
clinic and bringing clinical experiences to the laboratory bench. The main objective of the University of Rochester
MSTP is to provide a unique and integrated environment for the rigorous and efficient training of future physician-
scientists. This is accomplished by immersion in basic science and clinical exposure through all program years
combined with a period of focused research leading to the PhD. Degrees are offered in a wide range of areas
that take advantage of the University’s highly collaborative and interdisciplinary environment, including basic
biomedical sciences with emphasis on specific organ systems, Biomedical Engineering, population-based
degrees in Biostatistics, Epidemiology and Health Services Research, and College-based programs such as
Chemistry and Optics. As described in this application, our institutional environment is comprised of outstanding
faculty, resources and infrastructure, that provide cutting-edge research training. One such resource, the Clinical
Translational Science Institute (CTSI), which has been continuously funded by a CTSA grant since 2006,
provides multiple opportunities that enhance the MSTP, including funded slots for the PhD years of MD-PhD
training and a PhD program in Translational Biomedical Science. The medical school continues its commitment
to the MSTP, filling 8 slots each year and supporting new initiatives to enhance training and recruitment activities,
including a new MSTP Summer Scholars Undergraduate Research Program. We have been successful in filling
our slots with highly motivated students who are passionate about biomedical research and successful in
competing for individual fellowships, publishing their work, and entering competitive, research-focused residency
programs. Coupled with the University of Rochester’s commitment to the MSTP, funds from this renewal will
ensure that current and future trainees develop the skills and insights to initiate and lead the translation from
science to human health as members of the Physician-Scientist Workforce.

Public health relevance
There is a great societal need for physician-scientists who work at the interface of clinical patient care and scientific investigation. The MSTP at the Univesity of Rochester equips future physician-scientists with an in- depth understanding of medicine and a rigorous research experience, allowing them to pursue careers that fill important positions in academic medicine and translate research discoveries to improve health.